Data Integrity Core

SUMMARY/ABSTRACT – DATA INTEGRITY CORE
The Data Integrity Core (DIC) will significantly advance our ability to address well-publicized issues of quality
and reproducibility of translational, clinical, and data science driven research by leveraging the NIH FAIR
(Findability, Accessibility, Interoperability, and Reusability) Guiding Principles. The goal of the DIC is to add
expert level input to challenge underlying assumptions and approaches to research, going beyond the classical
timely expert review and enhancements to proposed work. For example, our core team will provide a unique,
independent critique for scientific strategies, ensuring diverse perspectives for methodologic approaches.
The DIC will focus on specific key functions: 1) identify and curate available and novel datasets to augment the
research being performed by University of Michigan ophthalmic and vision researchers; 2) work with University
of Michigan researchers to collate and share effective data-use strategies across research programs, including
the development of innovative, cutting-edge approaches in NIH-funded grants; 3) consult with and assist
researchers to ensure appropriate analytical support, including performing granular external code review of
modelling to elevate the rigor and reproducibility of investigations and the interoperability and reusability of the
data generated; and 4) interface and steward researchers to University of Michigan and global resources, such
as high-performance computing clusters, data management and storage facilities, and other University of
Michigan cores and faculty. The impact of the DIC will be to greatly enhance the application and effectiveness
of advanced data analytic strategies and accelerate the rigorous application of FAIR principles to vision
research.
The Core will serve a diverse group of University of Michigan NIH-funded vision scientists, spanning the
spectrum from basic scientists to clinical investigators to health services and community-engaged researchers.
In so doing, it will greatly enhance multidisciplinary, translational collaborations at Michigan and across the
larger vision research community globally. The DIC staff will be available both virtually and in a dedicated suite
within the Brehm tower of the Kellogg Eye Center, readily accessible to vision scientists. The Core will be
staffed by Dr. Chris Andrews and directed by Drs. Maria Woodward and David Musch. Scheduling of DIC staff
time will prioritize NEI R01-funded investigators, followed by NEI K-award recipients, other NIH R, U, and P
funded scientists, other PHS U, R and P equivalent funded grants, and other vision scientists.